Molecular Transport of IFT Complexes in Leishmania

Abstract/Summary:
Leishmania are obligate, intracellular parasites that are the causative agent of leishmaniasis—a disease
responsible for an estimated 1 million global infections each year, with ~70,000 fatalities. Therapeutics are
limited, and are generally restricted to general use, anti-protozoan drugs that lack efficacy, thus presenting
considerable threat to public health worldwide. Leishmania entry into host cells is mediated by flagella/cilia: a
hair-like organelle that protrudes from the pathogen body and beats to create motion—allowing Leishmania to
swim and attach to the host cell.
Flagella use an active transport system called intraflagellar transport (IFT) to shuttle proteins between the base
and tip. Because flagella do not contain ribosomes or proteasomes, IFT regulates all proteins inside the
flagellum and thus maintains flagellum-dependent transduction pathways—including those required for
Leishmania pathogenesis. Motor proteins move cargo along doublet microtubules that span the length of each
flagellum. Cargo is linked to these motors via adaptor proteins: large multi-subunit complexes—including IFT-A,
IFT-B, and the BBSome—that polymerize along the microtubules to form intraflagellar trains (IFT trains).
However, IFT train assembly and transport mechanisms are poorly understood. The proposed work
investigates two major components of IFT: assembly and in situ interactions of the IFT-B complex (Aim 1)
and the interaction between the BBSome and the IFT-A complex (Aim 2).

Public health relevance
Project Narrative: Leishmania parasites are the causative agents of leishmaniasis, a disease responsible for an estimated 1 million global infections with ~70,000 annual deaths. Leishmania pathogenicity is dependent on flagella—hairlike organelles that mediate pathogen motility and host cell recognition. Here, we investigate structures and mechanisms of intraflagellar transport that move protein cargo between the base and tip of the flagellum.